PrEParados: A Multi-Level Social Network Model to Increase PrEP Enrollment by Latino MSM Self-Identified as Gay, Bisexual or Straight in Miami

Project Summary/Abstract
I am a Latina PhD student at the University of Miami Miller School of Medicine who is committed to addressing
two health problems that disproportionally impact Latino men who have sex with men (LMSM): HIV and mental
health conditions. The purpose of the parent R01 PrEParados (Spanish for “prepared”) is to determine how
friendship, sexual and venue-based networks impact PrEP encouragement, initiation, and adherence. This
R01 is currently being implemented in Miami-Dade County (Miami), the epicenter of the HIV epidemic in the
US, with LMSM. The goal of this diversity supplement is to use innovative social network modeling to (1)
examine intersectional mental health disorders exacerbated by negative network structures and dynamics
(e.g., isolation, loneliness) in LMSM’s PrEP initiation, and (2) understand how social and health service
networks can increase LMSM’s enrollment in bundled PrEP and mental health treatment programs. Training
Component. My mentoring team includes Dr. Mariano Kanamori (main-sponsor), Dr. Adam Carrico (co-
sponsor), and Dr. Susanne Doblecki-Lewis and Dr. Steve Safren (advisors). The training aims are: (1) provide
me with a framework to conduct research to understand and describe the nature and extent to which HIV and
mental health disparities occur as well as to comprehend the etiology and potential factors associated with
disparities in accessing PrEP and mental health services with an emphasis on LMSM, (2) enhance my
knowledge of relevant perspectives, practices, and problems in bundled mental health and PrEP randomized
clinical trials, (3) train me in cutting-edge social network analytical skills to fully leverage my ability to
understand mechanisms influencing LMSM’s social networks and their service networks, and (4) prepare me to
apply for a F31 grant and build the foundation for applying for a K99/R00 and subsequent full-time academic
appointment at a nationally recognized academic institution. Research Component. This diversity supplement
is within the scope of the parent award’s aims because it provides new information on how to enhance PrEP
interventions with social network components. A cross-sectional study will be implemented using data from the
parent award (Aim 1) and service network data I will collect for this study (Aim 2). The Aims are: Aim 1:
Examine intersectional mental health disorders due to network structures and dynamics (e.g., isolation,
loneliness) in LMSM’s PrEP initiation. Aim 2: Examine how health and social services can leverage network
collaborations to increase access to both mental health and PrEP programs. This project is addressing the
need for a comprehensive understanding of the role of mental health conditions and social networks in
LMSM’s PrEP initiation during the pandemic. Furthermore, this diversity supplement will prepare me for my
long-term goal of pursuing an independent academic career in which I develop innovative social network-
based randomized clinical trials that facilitate the enrollment in bundled PrEP and mental health programs for
LMSM.

Public health relevance
Project Narrative The proposed research will examine intersectional mental health disorders exacerbated by negative network structures and dynamics (e.g., isolation, loneliness) in Latino men who have sex with men’s (LMSM) PrEP initiation and understand how social and health service networks can increase LMSM’s enrollment in bundled PrEP and mental health treatment programs. This study will be implemented using data from the parent award and service network data I will collect for this study. Study results will inform the submission of an F31 and subsequent K99/R00 application to develop and implement bundled PrEP and mental health services for LMSM.